Developmental Funds

The Hollings Cancer Center (HCC) at the Medical University of South Carolina (MUSC) requests $180,000 per year in developmental funds, 17% of the overall direct Cancer Center Support Grant (CCSG) request, that will be used specifically to: ? Provide pilot research funding to HCC members annually, a total of $80,000 per year, to promote translational research in high priority areas as articulated by the HCC leadership. ? Provide funding, $100,000 per year, for start-up packages for high priority new faculty recruitment. These CCSG Developmental Funds will be employed to directly fulfill key components of the HCC's strategic research plans for 2014-2018.

Public health relevance
The Hollings Cancer Center (HCC) requests Developmental Funds from the Cancer Center Support Grant to fund pilot research projects and recruit new faculty to MUSC. Both endeavors will support the overall mission of the HCC, which is to reduce the cancer burden in South Carolina and beyond.